Image-guided irreversible electroporation directed CAR T-cell delivery to solid tumors

PROJECT ABSTRACT
Tumor infiltrating lymphocytes (TILs) can significantly increase the success of immunotherapy. Solid tumors
present barriers to TIL penetration and function. Strategies to increase TILs and their function are challenged
by the inability to direct the delivery of T cells into solid tumors and a lack of techniques to predict their uptake.
Through this proposal, we will develop the use of image-guided irreversible electroporation (IRE) as a novel
approach to promote TILs in solid tumors. IRE is clinically used for the treatment of solid tumors by applying
microsecond long electric pulses that kill cells through rapid permeabilization of the cell membrane. A unique
feature of IRE is that, while killing cells, it spares the extracellular matrix and blood vessels within the treatment
region, which is ideal for stimulating local inflammation and promoting TILs. We will investigate our proposed
strategy in translational mouse models and in patients with malignant pleural mesothelioma (MPM), which is a
solid tumor where a higher ratio of cytotoxic TIL to immunosuppressor cells has already been shown to
increase patient survival. In our experiments, we will use chimeric antigen receptor (CAR) T cells that are
genetically modified to recognize mesothelin, a cell surface antigen that is overexpressed on mesothelioma
cancer cells. Based on prior work by the PIs' team, we rationalize that cell death from IRE: (i) can be imaged
using intra-procedural FDG-PET; (ii) can generate an intratumoral chemokine gradient that promotes TILs; and
(iii) therefore, FDG-PET guided IRE can serve as a surrogate to both map and drive tumor-targeted CAR T-cell
delivery. Furthermore, our strategy of IRE-directed CAR T-cell infiltration can be repeated using electric pulse
parameters designed to be cancer cell-targeted/TIL-sparing, thereby augmenting immunotherapeutic efficacy.
The long-term goal of our work is to develop image-guided IRE as a platform for predictable, reproducible, and
controllable delivery of CAR T cells and other cellular anticancer therapies to solid tumors. In Aim 1, we will
create an integrated tumor immune microenvironment map (iTIMM) combining FDG-PET imaging, computer
simulations, and quantitative multiplex immunofluorescence histology to develop a tool that will determine T-
cell localization in solid tumors treated with IRE. iTIMM will then be used to develop a clinically relevant
protocol that, in combination of intravenous administration of T cells, will be used to increase TILs. In Aim 2, we
will use dual imaging with PET (cancer cells) and bioluminescence imaging (T cells) to validate IRE pulse
parameters to selectively enrich and increase functional CAR T cells within MPM. In Aim 3, we will perform a
pilot clinical trial using PET-guided transthoracic IRE of MPM prior to resection to validate the concept of iTIMM
and its effect on TILs. The modulation of the tumor microenvironment with image-guided IRE to map and
localize T-cell delivery, promoting CAR T cell function, and translational validation of iTIMM presents innovative
rational combinations of clinically used techniques and is an ambitious attempt to address a key challenge to
solid tumor immunotherapy.

Public health relevance
PROJECT NARRATIVE Tumor infiltrating lymphocytes (TILs) are essential to successful solid tumor immunotherapy. Herein, we propose to promote TILs in solid tumors through image-guided irreversible electroporation and adoptive transfer of genetically modified CAR T cells, thus further augmenting CAR T-cell function by T-cell-sparing repeat IRE.